Ultra-broadband multimodal microscopy with a catadioptric lens

Abstract.
Virtually all optical microscopes for biological imaging are based on refractive objective lenses.
The performance of these lenses approaches the theoretical limit, however, their use is limited to
the visible to near-infrared spectral range. Even within this range, their performance is only
guaranteed over a relatively narrow range, and broadband use is invariably affected by chromatic
aberrations. Another problem is the group delay dispersion that these lenses introduce to short
optical pulses, which reduces the efficiency of nonlinear optical (NLO) signal generation in the
microscope. Taken together, these shortcomings seriously compromise the imaging properties of
several NLO imaging modalities such as three-photon excited fluorescence and third-harmonic
generation. In addition, refractive objectives simply cannot be used for NLO techniques that
incorporate excitation light in the mid-infrared (MIR) range, such as photothermal imaging and
sum-frequency generation, promising technologies based on MIR molecular contrast. The only
viable alternative is the all-reflective Schwarzschild-Cassegrain (SC) objective, which is inherently
achromatic but suffers from a non-ideal point spread function and a center obscuration that limits
throughput. Because of these limitations, SC lenses have not found widespread use in biological
imaging applications. This lack of performance is also the reason why advances in exciting new
MIR-based NLO imaging technologies have been stifled: there simply are no high-performance
high numerical focusing options available to support these emerging imaging technologies.
In this project, we develop a novel high numerical aperture lens that overcomes all
limitations of the SC focusing lens. Leveraging refractive and reflective elements based on a non-
concentric layout, this new catadioptric design features transmission from the ultra-violet to the
mid-infrared, exhibits a wide field of view and extended working distance, dramatically reduces
group delay dispersion and significantly improves throughput by eliminating the center
obscuration all together. This lens not only advances existing NLO modalities that rely on
broadband radiation, but also enables new technologies such as photothermal imaging and SFG
microscopy that have thus far suffered from low performance focusing optics. Ultimately, this
imaging tool will enable researchers to perform single-cell and tissue studies for a variety of cross-
cutting biomedical applications regardless of the illumination source used.

Public health relevance
Project Narrative. In this project, we design, fabricate, and validate a new type of microscope objective, namely a catadioptric objective lens in a non-concentric geometry. This lens overcomes all limitations of commercial reflective objectives, which are invariably based on the Schwarzschild-Cassegrain design. The new lens features spectrally broad operation from the ultraviolet to the mid-infrared, a wide field of view, unparalleled throughput and a well-behaved point spread function, thus enabling new and advanced nonlinear optical technologies that have so far been stifled by the lack of a high-performance objective lens. To support such innovation, we unite a team of expert microscopists and optical engineers to prototype and validate this lens through multimodal imaging of tissue biopsies at the single-cell level.